ABCD-USA Consortium: Data Analysis, Informatics and Resource Center

Project Summary
This administrative supplement to the Adolescent Brain Cognitive Development (ABCD) Study:
Data Analysis, Informatics, and Resource Center (DAIRC) will enable the completion of whole
genome sequencing (WGS) for approximately 3,100 remaining participants and enhance the
infrastructure necessary to return clinically actionable genetic findings to eligible individuals, in
accordance with ACMG guidelines for secondary findings. To support these goals, we propose
to expand DAIRC’s bioinformatics and DevOps teams and invest in long-term storage and
tracking systems that ensure secure data processing, harmonization, and management of the
return-of-results workflow. Participants identified as having medically actionable variants will be
offered CLIA-certified confirmatory testing and genetic counseling. This work will enhance the
scientific and clinical utility of ABCD genomic data and provide a scalable model for ethically
integrated return of results in pediatric research.

Public health relevance
Project Narrative This project will support the completion of whole genome sequencing (WGS) for the full ABCD Study cohort and enable the responsible return of clinically actionable genetic findings to participants and their families. By enhancing the ABCD Data Analysis, Informatics, and Resource Center’s (DAIRC) infrastructure, personnel, and workflows, this supplement will help translate genomic data into meaningful health information, support early detection of risk for serious medical conditions, and provide access to genetic counseling and confirmatory testing. These efforts align with national priorities to promote access to genomic medicine, support data sharing and stewardship, and improve child and adolescent health outcomes.